Stability and Change in Psychosocial Risk and Protective Profiles for Substance Use in Adolescents With and Without ADHD: A Person-Centered Approach

PROJECT SUMMARY/ABSTRACT
Attention-deficit hyperactivity disorder (ADHD), a neurodevelopmental disorder characterized by difficulties with
sustained attention, hyperactivity/impulsivity, and executive functioning, is a well-established developmental
risk factor for substance use, including during the adolescent period. Alcohol, cannabis, and nicotine/electronic
nicotine delivery system (ENDS) use is particularly prevalent during adolescence. Unfortunately, earlier
initiation of substance use (SU) during adolescence is associated with high-risk drinking behaviors, problems
associated with cannabis and nicotine use, and overall poorer substance use related outcomes in adolescence
and adulthood. This is particularly true for adolescents with ADHD, who initiate substance use earlier and
escalate substance use faster than adolescents without ADHD. Dynamic interactions in multiple ecological
domains, including peers, family, and school have been implicated in the etiology of adolescent SU. ADHD is
associated with vulnerability across all of these domains and pathways to SU through individual psychosocial
and ecological factors have been identified in youth with ADHD. However, risk and protective profiles for SU
spanning multiple ecological domains remain largely underexplored in adolescents with ADHD, and little work
has harnessed data-driven, person-centered (as opposed to variable-centered) statistical methods to explore
dynamic changes in both exposure to psychosocial risk and protective factors and the onset of substance use
behaviors, in youth with and without ADHD. To address these gaps, the aims of the proposed study are to: (1)
Utilize multigroup latent profile analysis (LPA) to identify whether profiles of psychosocial risk and protective
factors for SU across peer, familial, and school contexts from early to middle adolescence (ages 9-14) are
similar or distinct for youth with and without ADHD. (2) Utilize latent transition analysis (LTA) to examine
patterns of stability and change in these risk and protective profiles for youth with and without ADHD across
adolescence. (3) Examine associations between shifts in profile membership across early adolescence and SU
behaviors (odds of SU initiation and frequency of SU) in middle adolescence (ages 13-14) for youth with and
without ADHD. This research is responsive to priority area 1.2 in NIDA’s 2022-2026 strategic plan of advancing
understanding of the influence of youth’s social ecologies developmental substance use trajectories. Funding
this project will provide critical experience to further the applicant’s career goals of becoming independent
investigator and set up her future work in developing prevention and treatment interventions targeting risky SU
in adolescents with ADHD by addressing critical risk and protective factors on the individual level.

Public health relevance
PROJECT NARRATIVE Adolescents with ADHD are at higher risk for early substance use, particularly alcohol, cannabis, and nicotine, often leading to poorer substance use outcomes compared to peers without ADHD. Psychosocial factors across peer, family, and school domains are thought to contribute to this vulnerability, but little research has used person-centered methods to examine the unique unfolding of these risk and protective factors across adolescence and the impact of this on substance use patterns of youth with and without ADHD. Understanding individual differences in combinations of and changes in ecological risk and protective factors for substance use over time for youth with and without ADHD may provide crucial context for identifying youth who are particularly vulnerable to poorer substance use outcomes and informing future substance use prevention and intervention targets.